Multi-center development of a novel diagnostic test for Alzheimer's disease

Summary
As the number of Alzheimer's disease (AD) patients increases rapidly, a simple and specific blood test to
diagnose AD is needed. Our recent research discovered that a single peripheral injection of pramlintide can
move amyloid-β peptide (Aβ) from the brain into the blood in AD mouse models, and the level of Aβ increase
in the blood correlates well with the existing amount of Aβ in the brain. Based on this finding, the proposed
study is to further the development of a blood test for AD patients that we initiated by a single injection of
pramlintide as the challenge for biomarker changes in blood. This challenge test will be a diagnostic test for
AD similar in principle to the glucose tolerance test that shows abnormalities specifically in diabetic patients.
The central hypothesis is that a single pramlintide injection will significantly induce a change in a
group of AD-related factors in the blood of AD patients but not in those with normal cognition, and
the signature of these changes will correlate with the AD biomarkers in the central nervous system
(CNS). We will recruit 240 subjects from 3 clinical research centers to conduct the pramlintide challenge test.
There will be three specific aims. Aim 1 is to investigate whether a single injection of pramlintide induces a
dose-dependent increase in Aβ in the blood of AD patients. Aim 2 is to investigate whether the pattern of AD
biomarker changes in the pramlintide challenge test correlates with AD biomarkers in CSF. Aim 3 is to
determine whether the pattern of AD biomarker changes in the pramlintide challenge test correlate with
amyloid burden in the brain. Pramlintide is non-amyloidogenic amylin analog, and is an FDA-approved drug
for diabetes with a favorable safety profile. Should our proposed study support the concept of the amylin
challenge test as a diagnostic test for AD, this test will be able to be conducted in a doctor's office.
1

Public health relevance
Project Narrative The proposed multi-center study is relevant to public health for two reasons: First, as the number of Alzheimer's disease (AD) patients increases rapidly, we urgently need blood tests for AD that are specific, simple and can be done in a doctor's office. The proposed study seeks to provide solid evidence on a challenge test with an amylin analog, pramlintide, to diagnose AD. Second, since there are no effective treatments for AD, this project will also provide information on whether pramlintide can be used as a safe drug for AD in humans since it reduces AD pathology and improves cognition in AD mouse models.